Novel Zeolite Photocatalyst for Reductive Dechlorination of Chlorinated VOCs

[unreadable] DESCRIPTION (provided by applicant): Zeomatrix, a small business, is proposing to research and develop a remediation technology for chlorinated volatile organic carbons (CVOCs). CVOCs are ubiquitous groundwater pollutants. Left on their own they persist in nature for over 100 years. Most are toxic to humans, and some (including trichloroethylene) have been linked to cancer. A recently completed 17 year study by the United States Geological Survey found that chlorinated VOCs are present in nearly every aquifer in the United States. It is estimated that full scale remediation of these compounds in groundwater will cost in excess of $200 billion. The product being developed is a visible light photocatalyst which will promote the rapid reduction of CVOC compounds to less toxic materials. Current commercial photocatalysts are employed as oxidative catalysts, and thus they are less efficient at remediation in the presence of dissolved organic matter, a common component of groundwater. Zeomatrix utilizes high throughput screening methods to rapidly and cost effectively develop new photocatalysts. The Phase I research will be performed using custom-designed parallel photocatalyst screening instrumentation in order to evaluate a large number of candidate materials and identify the optimal reductive photocatalyst. The research will be focused on the following specific aims: one, to synthesize an array of catalyst support geometries based on design of experiments (DoE) protocol and using an automated deposition system custom-engineered by Zeomatrix to deposit various metal/metal oxide combinations and then screen for reductive photocatalytic activity under visible light; and, two, to screen the reductive photocatalysts selected from the initial screening experiments for activity versus chosen test compounds (trichloroethylene, trichloroethane), under a range of experimental conditions (pH, ionic strength, dissolve organic content). Selection of the optimal photocatalyst will be based on rapid degradation kinetics (turn over frequency), and efficacy under adverse conditions (high ionic strength, pH extremes, and high dissolved organic content). The results of the Phase I research will be used to determine the feasibility of applying the selected photocatalyst for the remediation of CVOCs. Phase II studies would be performed to further optimize the photocatalyst, and to perform a large scale pilot study on actual polluted groundwater. The combination of rapid kinetics with the use of low cost visible light would make this an attractive remediation option to address the extensive problem of CVOC contamination. [unreadable] [unreadable] The goal of this research is the development of a novel remediation technology for the break down of chlorinated volatile organic carbons in water. Chlorinated volatile organic carbons are found in nearly every aquifer in the US. Left on their own they persist in nature for over 100 years. Most are toxic to humans, and they accumulate in fatty tissue making them a danger to human health even at low levels. Some have been linked to cancer and over twenty are currently regulated in public water supplies by the United States Environmental Protection Agency. [unreadable] [unreadable] [unreadable]